Assessment of the Impact of antihypertensive Medications on vascular and renal outcomes in Chronic Kidney Disease (AIM-CKD)

Title: Assessment of the Impact of antihypertensive Medications on vascular and renal outcomes in Chronic
Kidney Disease (AIM-CKD)
Abstract
Chronic kidney disease (CKD), characterized by enduring damage to kidney function, poses a significant public
health concern, impacting around 15% of the adult population in the United States. CKD patients commonly
experience heightened adverse cardiovascular effects, which are associated with an elevated risk of mortality.
Foundational treatment strategies for slowing CKD progression involve blood pressure-lowering agents,
including renin-angiotensin system inhibitors and calcium channel blockers. These medications also exhibit
potential vasodilatory and anti-inflammatory properties. Nevertheless, the impact of these therapies on
cardiovascular disease outcomes in CKD patients is still in debate, and the tradeoff between risks and benefits
remains unclear due to limited clinical trials conducted thus far. To address this knowledge gap, we intend to
leverage data from two extensive studies: the Chronic Renal Insufficiency Cohort (CRIC) and the Systolic
Blood Pressure Intervention Trial (SPRINT). Our goal is to estimate and compare the effects of medications on
cardiovascular risks in CKD patients using novel and advanced causal inference methods. We recognize that
analyzing real-world data poses statistical challenges (e.g., time-varying treatment administration, competing
risk of death, treatment combination). However, these complexities cannot be directly addressed by current
causal inference techniques or may be addressed inefficiently. Our proposal focuses on time-to-event
outcomes, which accommodate detailed information, including the timing and duration of disease outcomes
that are crucial for understanding the natural progression of the disease and assessing the potential
effectiveness of interventions. Preliminary work has demonstrated the promise of our novel dynamic propensity
trajectory matching (DPTM) techniques, which guarantee further evaluation through theoretical and extensive
simulation studies conducted under various scenarios. Ultimately, we aim to develop user-friendly R software
packages and a Shiny app to facilitate the broader use of our research findings for the benefit of the public.

Public health relevance
Public Narrative It is well known that patients with chronic kidney disease (CKD) are at a high risk of cardiovascular disease (CVD). However, the choice of antihypertension medications for blood pressure-lowering is still a topic of debate. The differences in the effects of these agents also remain unclear due to the limited number of clinical trials conducted. To address these questions, we will leverage data from two large-scale observational and clinical studies, namely the Chronic Renal Insufficiency Cohort (CRIC) and the Systolic Blood Pressure Intervention Trial (SPRINT). Our goal is to exclusively investigate the effects of these medications in CKD patients by employing advanced causal inference techniques. The methods we propose are general and can be applied to other studies and medical specialties facing similar analytical challenges. Software packages and a Shiny app will be publicly available for applications in research and clinical practice.